A novel platform for synthetic generation and statistical obfuscation of tabular clinical data, simulated images, and machine-generated text

PROJECT SUMMARY
Data is a critical and highly valuable commodity, driving meaningful change in our society,
especially when it pertains to patient care and biomedical research. Currently, institutions pay
inordinate sums to increase, regain, and complement their data panels. As an extra burden,
data legislation and privacy protection regulations introduce barriers to forming effective
partnerships between business, clinical, research and educational organizations. As a result,
approximately 80% of medical data today can’t be readily shared because they contain
personal, protected or sensitive information and remains unstructured and untapped after they
are created. There is a growing and urgent unmet need for technology solutions that balance
research and commercial organizations interests by supporting flexible general-purpose
analytics while guaranteeing privacy protection.
There are no effective mechanisms to enable
data sharing without either risking inappropriate release of sensitive information or potential
degradation of the information content. The currently available few protocols and algorithms for
modeling, processing, interrogating, and ultimately sharing large sensitive data (e.g., thousands
and millions of records with thousands of heterogeneous features) all share significant
limitations and their practical use still lags behind research progress. Two major unmet needs in
the data sharing industry are i) the inability to return de-identified clones of the raw data, and ii)
lack of scalability requirements of production deployments. GrayRain, LLC is an early-stage
Software-as-a-Service company developing a novel platform for statistical obfuscation and de-
identification of sensitive structured (numerical, categorical tabular data) and unstructured
information (e.g., clinical text, doctors/nurses notes and clinical images, such as MRI, PET). The
core of GrayRain’s technology is the novel patented statistical obfuscation algorithm, DataSifter. The
technology proposed in this STTR Phase I application will significantly increase the number of
secure data transactions in the healthcare sector and beyond, enabling data sharing with fully
controllable risk of identification of any sensitive information, including, but not limited to PHI
(personal health information), demographic information, or socioeconomic status. GrayRain’s
technology is able to produce de-identified clones of raw tabular data, addressing a major limitations
encounter across existing data anonymization protocols. As far as scalability, the main goal of this
STTR Phase I is to establish feasibility of GrayRain to accurately and efficiently (re: scalability) de-
identify and share large-scale complex EHR data repositories with a controlled risk of disclosing
protected or personal health information .

Public health relevance
PROJECT NARRATIVE S haring of Big Biomedical Data, including millions of records with thousands of complex sensitive features, provides research and commercial organizations enormous opportunities for disruptive healthcare innovations. There is a growing and urgent unmet need for technology solutions that allow sharing of critical proprietary data across stakeholders and at the same time complying with strict privacy regulations (e.g., HIPAA and GDPR). GrayRain LLC proposes to productize the DataSifter, our unique patented statistical obfuscation technique, as a novel, scalable, cost-effective, reliable and efficient tool for the obfuscation of sensitive electronic health data, to balance these competing interests by supporting general- purpose analytics while guaranteeing privacy protection.